CD25-mediated feedback control of BCR-signaling and its oncogenic mimics

PROJECT SUMMARY
B cells critically depend on continuous survival and proliferation signals from a functional B cell receptor (BCR).
Likewise, in ~50% of B cell malignancies, the tumor clone is driven by an oncogenic BCR-mimic. Oncogenic
mimics of BCR-dependent proliferation and survival signals include BCR-ABL1 (Ph+ ALL), viral oncoproteins (e.g.
EBV), RAS- and NF-κB-pathway activating lesions (Hodgkin's lymphoma, PMBL, ABC-DLBCL, hairy cell
leukemia, Waldenström's macroglobulinemia). In preliminary studies, we found that CD25 is selectively expressed
on malignant B cell clones driven by oncogenic BCR-mimics. While CD25 functions as IL2 receptor α-chain on T
cells, we recently discovered that CD25 is a critical feedback regulator of BCR signaling and oncogenic BCR-
mimics in human B cell tumors. Genetic experiments demonstrated that CD25 is critical for the initiation of B cell
leukemia and lymphoma in transplant recipients. Surface expression is rapidly induced by activity of BTK and
PKCδ downstream of the BCR and induced by FOXM1 and NF-κB at the transcriptional level. CD25 then recruits
an inhibitory complex to the cell membrane to reduce and recalibrate BCR signaling or oncogenic mimicry of
BCR-signaling. Analysis of three clinical cohorts revealed that high expression levels of CD25 are associated with
poor clinical outcome in various B cell malignancies. While CD25 expression is associated with drug-resistance,
inhibition of CD25 or disabling of CD25-dependent feedback control sensitizes multiple B cell malignancies to
conventional drug-treatment.
Based on these and other findings, we propose three Aims to (1) elucidate mechanisms of CD25 regulation, (2)
explore usefulness of pharmacological subversion of CD25-mediated feedback control and (3) targeted
eradication of CD25+ cells by CART25 cells and antibody-drug conjugates (ADC) as therapeutic adjuvant.

Public health relevance
PROJECT NARRATIVE We recently revealed that CD25 functions as a critical feedback regulator of B cell receptor (BCR) and oncogenic mimics of BCR signaling in aggressive B cell malignancies. CD25-dependent feedback regulation is induced by oncogenic mimics of BCR signaling (e.g. BCR-ABL1, EBV-oncoproteins, BRAF, activating NF-κB pathway lesions), enables robustness of oncogenic signaling and is critical for the initiation of disease in transplant recipients. We hypothesize that CD25-dependent feedback control of oncogenic signaling represents a novel drug-target in aggressive B cell malignancies. We propose three Aims to (1) elucidate mechanisms of CD25 regulation, (2) explore usefulness of pharmacological subversion of CD25-mediated feedback control and (3) CD25 as target for immunotherapy (CART25) and antibody-drug conjugates (ADC).